A Mobile TXT-based Intervention to Improve Adherence to Adjuvant Hormone Therapy and Symptom Management for BCa Survivors

PROJECT SUMMARY/ABSTRACT
Substantial evidence reports that adjuvant hormone therapy (AHT) decrease breast cancer (BCa) recurrence
and mortality, however, rates of adherence to AHT have reported to be as low as 25%, which can lead to poor
survival outcomes. Side effects from AHT can negatively affect HRQOL and are one of the most commonly
cited reasons for nonadherence to AHT. Patients also reported a range of barriers to AHT adherence,
including: at the cognitive level, women report negative beliefs about the efficacy of AHT, low cancer
recurrence fears, and a lack of behavioral cues to prevent unintentionally missing doses. At the affective level,
barriers include distress about side effects and high concerns regarding the impact of its long-term use. At the
interpersonal level, low family support and poor communication with providers have been associated with AHT
nonadherence. However, little is known about effective AHT adherence-promoting interventions. Guided by our
team’s Cognitive-Social Health Information Processing Model and health communication best practices, an
evidence-based mobile text messaging intervention (Txt2Adhere) was iteratively developed with patient-
centered input and clinical and behavioral evaluation. The goal of Txt2Adhere is to address 1) cognitive
barriers by increasing knowledge about AHT, reinforcing AHT benefits, and providing skills for medication
uptake; 2) affective barriers by normalizing feelings and providing self-management skills to manage distress
and symptoms; and 3) interpersonal barriers by enhancing women’s communication skills with families and
providers. In a pilot study, Txt2Adhere participants reported significantly higher adherence to AHT at 2 months,
compared with a UC group. The proposed study innovatively builds on the success of our pilot study by: 1)
expanding the intervention period to six months; 2) following participants for 1 year; 3) adding a wireless smart
pill bottle component; and 4) including a larger sample. For the phase 1 of the proposed study, focus groups
and a behavioral scientific advisory panel review will be conducted to finalize the refinement and enhancement
of Txt2Adhere. During phase 2, we will evaluate the efficacy of Txt2Adhere on a diverse group of BCa patients
(N=300) in comparison with a UC group, recruited from Fox Chase Cancer Center and Temple University
Hospital. A total of four assessments will be conducted: baseline, 3-months, 6-months, and 12-months (6-
months post-intervention) follow-ups. Outcome and process variables include assessment of AHT adherence
rate (measured by AdhereTech smart pill bottles), symptom distress, theory-based variables, intervention
participant satisfaction with and usage of the intervention. We hypothesize that Txt2Adhere participants will
report significantly higher levels of AHT adherence rates and lower levels of symptom distress than the UC
group. We will determine if the reduction in cognitive-affective barriers mediates the effects of the intervention.
We will explore if being minority, younger or older moderate the effects of the intervention. The study is
significant because Txt2Adhere has the potential to reduce persistent AHT nonadherence among BCa women.

Public health relevance
PROJECT NARRATIVE While studies have found that adjuvant hormone therapy for hormone-sensitive breast cancer dramatically reduces recurrence and mortality, discontinuation of this treatment is high, which might compromise its effectiveness. The current lack of successful interventions targeting patient barriers to adjuvant hormone therapy adherence represents a missed opportunity to promote survival in this fast-growing breast cancer subgroup. To address this gap, the proposed study, adopting an innovative and practical mHealth approach, is aimed to evaluate an evidence-based and theory-guided text messaging intervention that will have the potential to improve breast cancer patients’ outcomes by proactively facilitating and promoting their adjuvant hormone therapy medication adherence and symptom management.